Role of Glutamine Metabolism During Osteoblast Differentiation and Bone Formation

PROJECT SUMMARY
Glutamine is a conditionally essential amino acid that has myriad uses in the cell. Aside from direct
incorporation into protein, glutamine can be metabolized to generate nucleotides, other amino acids, the Krebs
cycle intermediate α-ketoglutarate (αKG) which is important for energy production and anabolic reactions, and
glutathione (GSH) to protect against oxidative stress. We recently determined that αKG and GSH are
particularly important glutamine derived metabolites that are required at distinct stages of osteoblast
differentiation. For example, our data indicates that αKG is required early in skeletal stem and progenitor cells
to regulate proliferation and osteoblast specification. GSH is required later in specified pre-osteoblasts to
govern osteoblast differentiation by neutralizing reactive oxygen species (ROS). Mechanistically, how αKG and
ROS regulate proliferation, specification and differentiation remains enigmatic. Moreover, the enzymes that
generate αKG from glutamine in osteoblasts have not been described. In this proposal, we will 1) establish the
necessity of glutamate oxaloacetate transaminase 2 (GOT2) dependent αKG synthesis to regulate osteoblast
differentiation and bone formation, 2) define the contribution of αKG to osteoblast energetics and intermediate
metabolism, 3) elucidate the molecular regulation of osteoblast differentiation by ROS, and 4) evaluate the
efficacy of antioxidants to rescue bone formation in a mouse model of human cleidocranial dysplasia. Our
findings will have broad implications in bone development, maintenance of bone mass, skeletal repair and
regeneration.

Public health relevance
PROJECT NARRATIVE Glutamine metabolism provides αKG and glutathione to regulate early and late stages of osteoblast differentiation, although the precise role of these two metabolites during physiological bone formation is not well understood. Data generated by this proposal will: 1) establish the necessity of Glutamate Oxaloacetate Transaminase 2 (GOT2) dependent αKG synthesis, 2) define the contribution of αKG to osteoblast energetics and metabolism, 3) define the regulation of RUNX2 by reactive oxygen species, and 4) establish the therapeutic feasibility of antioxidants to protect RUNX2 and stimulate bone formation patients with cleidocranial dysplasia. Our findings will have broad implications in bone development and the maintenance and regeneration of bone mass.